Enhancing cone survival in retinitis pigmentosa through cell-specific therapeutic CRISPR editing of a roxadustat target

PROJECT SUMMARY
Retinitis pigmentosa (RP) is the most common inherited retinal dystrophy (IRD), caused by more than 3,100
mutations in 80 genes that are primarily specific to rod photoreceptors. Following major rod death phase, cone
death occurs regardless of the underlying gene mutations. Currently, there exists a knowledge gap in
understanding how aerobic glycolysis in photoreceptors impact the delicate “metabolic coupling” between rods
and the retinal pigment epithelium (RPE) in RP. The long-term goal of this project is to develop a therapy that
will preserve cone function in patients with RP. The objectives of this proposal are to investigate how metabolic
dysregulation due to lactate deficiency contributes to photoreceptor death in RP, test a novel metabolome
reprogramming strategy, and fulfill important safety requirements for filing a Pre-Investigational New Drug
application. The hypothesis is that reprogramming rod and cone aerobic glycolysis will promote cone survival in
RP independent of the underlying rod-specific gene mutations. This hypothesis has been formulated based on
the applicant’s strong preliminary data. The rationale for the proposed research is that by targeting a metabolic
pathway common to many of the genetically heterogeneous forms of RP, cone function may be preserved for
the equivalent of 10 or more human years, which would have a tremendously positive impact on the lives of
patients with RP. This hypothesis will be tested by pursuing three specific aims: 1) Investigate whether
photoreceptor-specific ablation of prolyl hydroxylase domain-containing protein (Phd), a metabolic enzyme that
inhibits aerobic glycolysis under normoxia, preserves cones by enhancing aerobic glycolysis in an autosomal
recessive RP mouse model; 2) Assess the efficacy and feasibility of enhancing cone survival and function by
ablating PHD2 in photoreceptors of a dominant RP mouse model ; 3) Establish the safety of therapeutic Phd2
editing in a WT and RP mouse model as well as human cells. Specifically, Aim 1 will determine whether
enhanced aerobic glycolysis in cone photoreceptors can promote their survival in a novel genetic mouse model.
Aim 2 will test the potential of gene therapy to slow photoreceptor degeneration by enhancing aerobic glycolysis
in a different mouse model of RP. Lastly, Aim 3 will define the pharmacokinetics and safety of the aerobic
glycolysis reprogramming vector. The approach is innovative because this will be the first example of cell-specific
CRISPR-mediated precision metabolic reprogramming and because the novel therapeutic-editing vectors can
be redeployed in future Phase I-IIA trials without modification. The proposed research is significant as it has the
potential to dramatically lower the cost of treatment, be applicable to dividing and nondividing cells, shape
ongoing CRISPR research, and ultimately define aerobic glycolysis as a safe and effective therapeutic target.

Public health relevance
NARRATIVE The proposed research is relevant to public health because it is expected to increase understanding of the pathogenesis of retinitis pigmentosa, the most common inherited retinal dystrophy, while testing a potential metabolic reprogramming therapy in a mouse model. Thus, the proposed research is relevant to the part of the NEI’s mission that pertains to supporting vision research to protect and prolong vision.